Programmable depletion and rescue platform to screen dynamic regulatory events during cellular differentiation.

PROJECT SUMMARY:
The mechanisms by which stem cells orchestrate their program to become functional differentiated
cells require accurate temporal regulation of specific gene expression programs. This complex network
requires precise temporal regulation of transcription and degradation processes to activate specific programs
in a coordinated manner. So far, most of the studies have explored the regulation of transcriptional pathways
and chromatin remodeling events during the differentiation process.
mRNA degradation processes may present an attractive and still poorly explored opportunity for
enhancing our understanding of the differentiation process. However, the lack of technologies that can capture
rapid mRNA degradation events over highly dynamic processes, such as differentiation, and the heterogeneity
of the mRNA degradation machinery in composition and expression patterns during differentiation have
presented major technical limitations to further exploring the role of mRNA degradation across the continuum
of the differentiation program. Here I propose to explore the existence of specialized RNA degradation
complexes that control the decay of specific mRNA subclasses at precise timeframes of the differentiation
process.
To test this, we will introduce a new platform that uses cutting-edge technologies integrated in
an innovative way to interrogate the continuum of the differentiation process at an unprecedented resolution.
Our programmable depletion and rescue strategy will allow us to control the expression level of each subunit of
complex mRNA degradation machinery robustly and with a precise time resolution of hours. By combining this
technology with a high-content imaging system, we can record phenotype changes and accurately determine
the specific impact of any perturbed protein on differentiation. Additionally, the use of this platform will guide us
to understand the exact gene regulatory network controlled by the machinery at the transcriptional and stability
level. The conceptualization and development of this workflow have the potential to impact a broader scientific
audience; due to its extremely high flexibility, it could be applied to the study of unlimited biological processes
or proteins.
In this essay, the application of our proposed platform has the potential to fundamentally
overturn the current view of how mRNA decay is dynamically regulated, providing a definite
understanding of the function of the degradation machinery on mRNAs and, at the same time, revealing the
broader impact of the degradation process on differentiation.

Public health relevance
PROJECT NARRATIVE: As cells differentiate, they activate signaling cascades that are precisely controlled in time to achieve the fully committed phenotype. However, current technologies are limited in their ability to characterize these precise temporal changes. To address this, we are developing a programmable platform that can reveal the impact of important mRNA players on cellular differentiation with unprecedented time resolution.